Synthetic and Spectroscopic Investigations of Sulfur Oxidation Reactions by Nonheme Iron Enzymes

Project Summary
In addition to its role as an amino acid, L-cysteine (Cys) is the precursor of numerous sulfur-containing
biomolecules that function as metabolites, micronutrients, and pharmaceuticals. The formation and
degradation of these compounds is often performed by mononuclear nonheme iron (MNHI) enzymes capable
of harnessing the oxidative power of molecular oxygen (O2). The proposed research aims to advance our
understanding of biological O2-activation by developing synthetic models of three types of enzymes that oxidize
Cys-derived compounds: (i) sulfoxide synthases, (ii) ergothioneine dioxygenase (ETDO), and (iii) persulfide
dioxygenase (PDO, also known as ETHE1). Sulfoxide synthases, found in some bacteria and fungi, catalyze
the oxidative formation of a C-S bond in the biosynthesis of S-containing natural products with therapeutic and
antioxidative properties. Two MNHI sulfoxide synthases have been reported to date, EgtB and OvoA, which
perform key steps in the biosyntheses of ergothioneine (Egt) and ovothiol, respectively. In some bacteria, the
degradation of Egt is initiated by a MNHI enzyme (ETDO) that catalyzes the S-dioxygenation of the thione
moiety. ETDO is closely related to the better-known family of MNHI enzymes known as thiol dioxygenases.
Finally, persulfide dioxygenase is required for mitochondrial degradation of the gaseous signaling agent H2S,
and loss of function is responsible for the human disease ethylmalonic encephalopathy. For all three classes
of enzymes, major questions remain regarding the nature of the catalytic mechanisms and the role of active-
site pocket in controlling the outcomes of O2-dependent reactions.
The research described in this application utilizes a bio-inspired approach that elucidates nonheme iron
catalysis through the development of structural and functional active-site models, the isolation and
characterization of reactive intermediates, and spectroscopic studies of synthetic and enzymatic species. The
specific aims of the proposed research are to: (i) gain insights into sulfoxide synthase activity through the
synthesis and characterization iron complexes that mimic the active-site structures and reactivity of EgtB and
OvoA, (ii) use synthetic models of PDO and ETDO to explore the O2 reaction mechanisms of enzymes that
catalyze the S-dioxygenation of non-thiol substrates, and (iii) probe the geometric and electronic structures of
OvoA through parallel spectroscopic studies of enzymatic and synthetic species. These interdisciplinary
studies will be carried out by a team of undergraduate students at Marquette University, who will be supervised,
mentored, and assisted by the PI and graduate students. All students involved in the project will receive
exceptional training in inorganic synthesis, crystallography, spectroscopic techniques, theoretical methods, and
the preparation of enzyme samples.

Public health relevance
Project Narrative Enzymes that utilize molecular oxygen (O2) to catalyze the oxidation of sulfur-containing compounds play critical roles in amino acid metabolism, signaling pathways, and the biosynthesis of nutrients that protect against oxidative stress in humans. These enzymes often require a nonheme iron cofactor that coordinates substrate(s) and activates O2 for sulfur dioxygenation or C-S bond formation. The proposed research aims to develop synthetic active-site models that will yield fundamental insights into the geometric structures, spectroscopic features, and catalytic mechanisms of sulfur oxidation reactions by nonheme iron enzymes.